IGF::OT::IGF BioreclamationIVT The effect of pre-analytical conditions on metabolite stability in urine Metabolomics Reference Sample Set Collection of 60 samples

BioreclamationIVT The effect of pre-analytical conditions on metabolite stability in urine Metabolomics Reference Sample Set Collection of 60 samples